The Claude D. Pepper Older Americans Independence Center (OAIC) at Northwestern University

ABSTRACT
We propose an Older Americans Independence Center (OAIC) at Northwestern University. Its mission will be to:
Generate innovative research that will enhance primary care for medically complex, older adults with
multiple chronic conditions (MCC) to achieve optimal health, function, independence and quality of life.
The Northwestern OAIC will catalyze research on: i) identifying modifiable clinical, healthcare system, and
social environmental determinants of chronic disease outcomes, physical and mental health, and quality of life
for older adults with MCC - especially those with frailty; ii) developing novel, practical, and scalable primary care
management strategies that align with patient priorities, improve health outcomes and maintain independence
for this vulnerable, at-risk, older adult population. The specific aims of the Northwestern OAIC are to:
Aim 1 Formalize a comprehensive, multidisciplinary, aging research program dedicated to improving
healthcare, functional independence, and quality of life for older adults with MCC.
Aim 2 Expand Northwestern training and mentoring activities to develop future leaders in geriatrics and aging
research who will transform healthcare to meet the needs of older adults with MCC.
Aim 3 Stimulate applied research on the innovative design of primary care models that align with the priorities
of older adults with MCC through aging-specific research resources and expertise in healthcare system
& technology design (`Design Core'), patient-reported outcomes measurement (`Measurement Core')
and quantitative & qualitative data analytics (`Analytics Core').
With strong institutional support and established infrastructure, we will organize internationally-recognized aging
research faculty at Northwestern and establish a formal presence as a collaborative center on aging. Junior
faculty with aging and MCC-related research interests will participate as mentored scientists; our OAIC will help
them establish a successful career trajectory as independent investigators. Three essential Resource Cores
(Design, Measurement, Analytics) will generate new methodological approaches for addressing MCC in primary
care and facilitate designing and testing health system interventions via pilot and developmental projects, and
through the use of an extensive portfolio of ongoing external studies. An Information Dissemination Core will
leverage broad regional and national primary care networks to share findings, proactively seek collaborations,
and find economies of scale in research and training activities among other OAICs and NIA centers.
The Northwestern OAIC will introduce a timely and highly complementary area of focus, while bringing
the greater Chicago community and Illinois into the national Pepper Center network.

Public health relevance
PUBLIC HEALTH NARRATIVE With the population of U.S. adults ages 65 and older growing at a rate 3 times that of those under 65, primary care providers must be prepared to care for the 80% of older adults who have complex care needs due to multiple chronic conditions (MCC). Our Northwestern Older Americans Independence Center will infuse geriatrics principles into primary care and align services with patients' priorities, enhance treatment decision making and promote self-management to optimize function, independence and quality of life among older adults with MCC.